Multimodal Characterization of Cardiac-Neurodevelopmental Genes

PROJECT SUMMARY:
Congenital heart disease (CHD) is the most common congenital anomaly and affects approximately 1% of
people. Neurodevelopmental delay and disability (NDD) are the most common extracardiac complications
among people with CHD, but clinical and surgical factors currently only explain approximately one-third of NDD
risk. Without knowledge regarding the molecular mechanisms that underly shared risk for altered heart and
brain development, people with congenital heart disease cannot benefit from early diagnosis, accurate
prognosis, and targeted treatments. Many genetic syndromes affect heart and brain development; we
anticipate that these seemingly divergent organs will share dysregulated gene expression during development.
Therefore, we propose to identify shared nodal biology disrupted in cardiac and neuronal progenitors with
haploinsufficiency of CHD7 or KMT2D, causes of genetic syndromes characterized by CHD/NDD. In support of
this goal, we have already generated human induced pluripotent stem cells (iPSCs) that are haploinsufficient
for CHD7 or KMT2D. With these reagents in hand, we will combine our expertise in iPSC methods and
computational biology to determine sources of shared genetic risk for heart and brain development, as well as
advance our approaches for functional assessment of variants.
The Overall Aim of this proposal is advance our understanding of the connection between CHD and NDD by
(1) identifying mechanisms by which syndromic CHD genes lead to alterations in both heart and brain
development, and (2) comparing the yield of transcriptomics, epigenetic and high-throughput high-dimensional
cell imaging to assess the functional impact of variants of uncertain significance from people with CHD in iPSC
models of heart and brain development. First, we will compare single nucleus and bulk transcriptomics,
chromatin accessibility, and cell morphology features of iPSCs that are haploinsufficient for CHD7 and KMT2D
as they differentiate to cardiac and neuronal progenitors. This combination of techniques will identify shared
and divergent direct targets of CHD7 and KMT2D in each cell lineage. Next, we will compare the ability of
transcriptomic and cell morphology approaches to determine whether missense variants of uncertain
significance from people with CHD are likely pathogenic, as cell morphology assessment can be higher
throughput and significantly lower in cost than transcriptomics. Together this proposal will employ multivariate
analysis of biological data in a way that builds upon the ongoing work supported by my K08 award and
generates new results that will support a future independent R01 grant application in 2027. These results will
contribute towards the long-term objective of understanding the molecular basis of heart development and
human disease to improve diagnosis, better define risks, and inspire novel treatments for patients.

Public health relevance
PROJECT NARRATIVE: The proposed research is relevant to public health because neurodevelopmental delay or disability are the most common extracardiac diagnoses in people with congenital heart disease, but known clinical and surgical variables only explain one-third of associated neurologic risk. Damaging changes to some genes cause both congenital heart disease and neurodevelopmental disorders, indicating there could be shared genetic mechanisms underlying both conditions. Therefore, I propose to develop a human induced pluripotent stem cell approach to assess of genetic regulation of heart and brain development as an in important step towards NIH’s goal of fostering fundamental creative discoveries as a basis for protecting and improving health through better diagnosis, treatment, and ultimately prevention.